PCPT and SELECT Cohorts: Core Infrastructure Support for Cancer Research

PROJECT SUMMARY/ABSTRACT
The SWOG Statistical Center in Seattle, Washington, served as the coordinating center for two large prostate
cancer prevention trials: The Selenium and Vitamin E Cancer Prevention Trial (SELECT) and the Prostate
Cancer Prevention Trial (PCPT). SELECT was a Phase III, double-blind, placebo-controlled study designed to
assess the effect of selenium and vitamin E, alone and in combination, primarily on prostate cancer incidence
and secondarily on other cancer incidence. SELECT randomized 35,533 men between 2001 and 2004. PCPT,
also a Phase III, double-blind trial, randomized 18,882 men to either finasteride or placebo between 1994 and
1997. Although schedules and requirements varied between the two studies, substantial serum, plasma, white
blood cells, and prostate tissue were collected on both, resulting in rich biorepositories.
Each had extensive prospective data collections which included diet and dietary supplements, quality of life,
physical activity, medications, other cancer diagnoses, cardiovascular endpoints, and treatment adverse events.
Although there have been significant scientific collaborations to date, there remain numerous opportunities to
further interrogate the clinical database and biobanks. Additionally, serum and plasma measures and extensive
genotyping data have already been obtained and are available for other investigators to use.
These cohorts are fully mature with 6,045 deaths and median follow-up of 18.4 years on PCPT and 3,762 deaths
and median follow-up of 10.1 years on SELECT. There have been 2,401 and 2,475 prostate cancers detected
during the trials plus an additional 890 and 338 prostate cancers identified via Medicare linkage in PCPT and
SELECT, respectively. Other primary cancers have also been documented either during the trials or through
data linkage. In addition to being able to extend the results of these well-conducted, randomized clinical trials
through linkages to Medicare, NDI and completed GWAS studies, these data can be used for epidemiologic
research as part of the ongoing consortium projects.
We request funds to continue to enrich the cohorts by collecting new data elements such as end point data from
Medicare and National Death Index linkages. We plan to update our linkages early in the upcoming grant period.
We also request support for the cohort team to develop detailed documentation and data sets to load into the
Cancer Epidemiology Data Repository, and we ask for continued support to provide a stable infrastructure for
the PCPT serum and PCPT and SELECT tissue repositories (all located at the University of Colorado). With
continued funding for the Statistical Center and some of our key scientific colleagues, we will be able to provide
administrative assistance and expertise to investigators who apply for additional funding to conduct studies using
our rich biologic repositories and clinical databases from PCPT and SELECT.

Public health relevance
PROJECT NARRATIVE By fully using the data and biologic samples from these two large cohorts with extensive follow-up, we will be able to evaluate risk factors for prostate and other cancers, and subsequent prognosis. We will be able to contribute clinical, demographic and biologic data, particularly genome wide measures, and we will provide access to biologic specimens from men diagnosed with prostate and other cancers to researchers to better understand the etiology of those cancers.